Developing Strategies to Decrease Facial Masking in Parkinson's Disease

ABSTRACT
Finding ways to keep people socially engaged as they grow older is becoming increasingly important to public
health as social engagement is necessary for aging well. Social engagement is particularly imperative for
managing disease symptoms for older adults with Parkinson’s disease (PD), a neurodegenerative movement
disorder. Facial masking is a motor symptom of PD that results in a decrease in facial expressivity. The reduction
in spontaneous facial expression can lead to the experience of stigma and can decrease quality of life and impair
relationships with family members and care partners. Facial masking affects expression of all spontaneous
emotion, but reduction in expressivity is often most noticeable in the expression of positive emotion. Facial
masking leads to a marked decrease in the production of Duchenne smiles, those that create crow’s feet around
the eyes. We know that older adults with PD are able to produce deliberate expressions of different emotions
with varying degrees of accuracy and intensity, but we do not know how effective these deliberate expressions
are at communicating emotion and reducing stigma in people with facial masking. The long-term goal of this
research is to evaluate the use of deliberate facial expressions as a viable strategy to alleviate the negative
social and emotional consequences of facial masking in people with Parkinson’s disease. The specific aims of
the proposed research are to (1) assess how older adults with PD experience producing deliberate expressions
and (2) test whether production of deliberate expressions in people with PD differ from production of deliberate
expression in healthy age-matched controls to see if they will be perceived similarly. Together the attainment of
these objectives will provide evidence for possible self-management strategies to improve interpersonal
functioning and quality of life in older adults with decreased spontaneous expression due to PD or other chronic
health conditions related to aging.

Public health relevance
NARRATIVE It is difficult for people with Parkinson’s disease (PD) to smile automatically when they are happy or frown automatically when they are sad due to decreased facial muscle activity, a symptom called facial masking. We will teach people with PD to deliberately create these expressions and determine whether this could increase their ability to communicate what they are thinking and feeling. An increase in their ability to communicate could help people with PD stay socially engaged, thereby better preserving their quality of life.